Unmasking neuromodulatory control of locomotion

Project Summary
Neuromodulators including dopamine and serotonin have profound effects on spinal circuits for locomotion. A wealth
of pharmacological manipulations has shown that drugs mimicking or blocking these neuromodulators can change the
properties of rhythmic motor output in the isolated spinal cord. However, these studies often conflict and cannot
capture the normal range of behaviors expressed in vivo. Furthermore, it is entirely unknown whether neuromodulators
are released onto different spinal targets across different behaviors. Finally, neuromodulatory neurons are highly
branched, making it difficult to disambiguate the spinal vs supraspinal consequences of their action. We will leverage
new tools for imaging and manipulating neuromodulator signaling, combined with the transparency and accessibility of
the young zebrafish, and a quantitative modeling approach, to understand the effects of dopamine and serotonin on
genetically defined components of the spinal locomotor circuit in vivo. First, we will measure the activity of
neuromodulatory axons during three distinct behaviors, testing whether dopamine and serotonin axons differentially
participate in these behaviors. Next, we will quantify neuromodulator release during these behaviors directly, both in
the whole spinal cord and in genetically defined populations of neurons with distinct contributions to locomotion. We
will then test the significance of descending neuromodulatory influence on spinal circuits by targeted axotomy that will
allow disambiguation of the spinal and supraspinal consequences of neuromodulator release. Finally, using newly
developed chemogenetic approaches, we will selectively block neuromodulatory receptors in motor neurons and
measure the consequences on the three distinct behaviors in freely moving animals. Throughout the project, we will
use experimental data to develop both single-segment and multi-segment computational models of neuromodulatory
action, and in turn use these models to make testable predictions about circuits and behavior. Together, these
experiments will reveal for the first time when and where dopamine and serotonin are acting in the spinal locomotor
circuit, and how their actions influence behavior in vivo.

Public health relevance
Project Narrative Decades of pharmacological work has shown that neuromodulators like dopamine and serotonin can affect the activity and output of the spinal cord to change movement, but it has been difficult to understand their natural functions and targets. We will measure where and when these neuromodulators are released in the spinal cord during locomotion, and use genetic tools to see exactly what types of neurons respond. We will also block the effects of these neuromodulators and study how movement is changed.